EFFECT OF ELEVATED PLASMA FREE FATTY ACID CONCENTRATION ON GLUCOSE TRANSPORT

The overall goal of this project is to define the earliest, inherited abnormalities responsible for muscle insulin resistance in NIDDM. The study was extended in order to increase enrollment.